Development of new tags for RNA visualization

PROJECT SUMMARY
RNA plays numerous roles in biology. In addition to its canonical role in the central dogma as an
intermediary between DNA genomes and protein products of translation, a myriad of roles have
been described for this molecule, including gene silencing (siRNA), regulation of translation
(bacterial riboswitches), and the translation machinery itself (rRNA). Despite the importance of
these roles in biology, tools for imaging RNA are not as robust as the suite of fluorescent proteins
that exist for readout of protein machinery. This project seeks to address this need by developing
new fluorescent aptamer tags for RNA visualization. This strategy has enjoyed considerable
success, particularly in bacterial systems, but deployment in complex systems (eukaryotic, whole-
organism) has been challenging. Recent work on RNA folding has shown that a noncanonical
RNA structure (a G Quadruplex) may impair the use of aptamers as tags in these systems. This
project seeks to select fluorescent aptamers that are not G-Quadruplexes. We will seek select
non-G-quadruplex-forming aptamers against a range of azo dyes (Aim 1) and endogenous
pigments (Aim 2) for robust live-cell imaging, and a long-range goal of whole-organism RNA
imaging. We will use these tags to characterize Lin28-mRNA interactions, which is not possible
with existing G-quadruplex-forming aptamers, because Lin28 is known to unfold G-quadruplexes
in RNA. We will also develop benchmarking tags for our selected aptamers by selecting non-G-
quadruplex-forming aptamers to known aptamer ligands, which we will use to compare our
selected aptamers.

Public health relevance
PROJECT NARRATIVE RNA is central to numerous biological processes that impact human health. In this work, we will develop new tools to enable fluorescent visualization of RNA. Thus, this project will transform our ability to study RNA in living organisms.